Neural Correlates of Sleep Homeostasis

The broad objective of this study is to identify the neural substrate(s) underlying the homeostatic sleep
response (HSR), i.e. enhanced sleepiness following prolonged sleep deprivation (SD). SD is experienced by
many due to lifestyle or vocational demands and is accompanied by impaired cognition, increased impulsivity,
and an increased likelihood of accidents. Furthermore, disrupted sleep is a common feature of many
neuropsychiatric disorders. Thus, understanding the mechanisms underlying the HSR is critical to develop
measures to combat the deleterious consequences of SD. Specifically, here we will address the central
question: “Are all neural wake-promoting systems equally important in triggering the HSR?” Our overarching
hypothesis is that basal forebrain (BF) cholinergic neurons (ChAT+) are modulated by glutamate and play a
privileged role in the HSR by causing the release of extracellular adenosine (ADex), which increases sleep by
inhibiting wake-promoting BF neurons, and thereby adjusts the state of the system towards its' set point.
Towards this goal, Aim 1, will test if BF cholinergic neurons, but not the brainstem pedunculopontine tegmental
(PPT) cholinergic neurons, are required for HSR. Aim 2 will test the hypothesis that within BF, only those non-
cholinergic wake-promoting neurons projecting to, and exciting, BF ChAT+ neurons will induce HSR. Aim 3
will test if stimulation of wake-promoting BF-vGluT2+ and PPT-vGluT2+ neurons will only induce HSR if BF
ChAT+ neurons are intact, i.e. the integrity of BF ChAT+ neurons is necessary to trigger the HSR. Finally, Aim
4 will test the dual role of BF ChAT+ neurons in promoting arousal and sleep homeostasis. We will use our
novel mouse `optodialysis' probes (Zant et al., 2016) that combine optical manipulation of selective neuronal
populations with in vivo microdialysis for detecting local neurochemical changes and/or application of
pharmacological agents. The successful completions of these investigations will further our understanding of
the neural substrates necessary for inducing the HSR, and thus will help in developing targeted
pharmacological interventions against the deleterious effects of sleep loss.

Public health relevance
Sleep loss, acute or chronic, is experienced by many and is a problem in our modern society. Sleep deprivation leads to excessive daytime sleepiness, emotional difficulties, poor job performance, an increased risk for a number of physical and mental health ailments and overall lower perception of the quality of life. Therefore, as proposed in this application, understanding how the brain responds to sleep loss and localizing the relevant target areas and neuronal subpopulations will inform therapeutic interventions.